Breathing, Full Volume Pulmonary Deposition Model to Transform Development of Aerosol Therapeutics

PROJECT SUMMARY
The biggest translational hurdle to advancing inhaled therapeutic and vaccine systems is predicting how they
will work in the lung. Predictions are challenged by the complex variability of airway structure and motion, the
tremendous surface area, and the highly coupled physical phenomena of orally inhaled and nasal drug products
(OINDPs). Given the high degree of complexity, there remain no preclinical tools capable of measuring spatial
deposition of an entire OINDP dose under simulated breathing conditions. Without knowing where aerosols
deposit in each individual, predictions of how well the therapeutic will work once there are severely insufficient.
This dearth of realistic in vitro models leads to a complete lack of high throughput screening approaches to new
inhalation therapies and creates significant challenges to establishing efficacy, toxicity, and/or bioequivalence
(BE) of OINDPs. Given this major bottleneck, pulmonary drug delivery remains a low pipeline priority, despite
the overwhelming potential to directly treat a plethora of respiratory diseases.
To address this, our lab has created a multiscale dynamic preclinical tool to spatial measure deposition as a
function of patient-specific breathing, anatomy, and disease state. Coined the “total inhalable deposition in an
actuated lung” (TIDAL) model, this platform leverages advances in additive manufacturing to recreate spatial
aerosol collection efficiencies across the five lung lobes. Our overall goal in this project is to realize the potential
of the TIDAL tool as an effective measure of inhaled deposition to address outstanding issues in inhalation
therapeutics. In Aim 1, we will validate healthy an adult TIDAL prototype with clinical dosimetry benchmarks for
aerosols of different average aerodynamic diameters and breathing profiles and identify an optimal upper airway.
In Aim 2, we will develop advanced features of the TIDAL model to capture interpatient variability, including
aspects of airway disease and altered ventilation. In Aim 3, we will upgrade the TIDAL model to include
representative humidity and mucosal mimicry to effectively evaluate DPI products. Progressing in parallel, these
aims will yield 1) a novel, integrated preclinical tool to measure spatial deposition and improve predictions of
inhalation efficacy (and/or toxicity), 2) broad correlations between regional deposition, BE, and existing in vitro
measures, and 3) a platform technology that can support therapeutic development for a wide range of respiratory
patients and disease pathologies. The integrated multiscale features of TIDAL within a single physical mode of
the entire lung volume will enable the first experimental quantification of how patient geometry, disease, breath
maneuver, and aerosol size combine to dictate lung response, leading to a transformative step-change in
inhalation therapeutic approaches. The project will catalyze new OINDP model creations and transform
opportunities in inhalation medicine.

Public health relevance
PROJECT NARRATIVE The biggest translational hurdle to advancing inhaled therapeutic and vaccine systems is predicting how they will work in the lung, owing to a dearth of experimental models capable of recreating the complex structure and physics occurring in the respiratory tract. With this work, we aim to exploit the “total inhalable deposition in an actuated lung” (TIDAL) model, a new tool capable of approximating spatial deposition under a complete breathing cycle, to quantitatively predict how distinct breathing sequences and diseased airway features influence deposition from varied inhaler devices and formulations.